Immune engineering of optimized sequential immunization strategies for HIV vaccines

Project Summary
Preclinical studies and early stage human trials evaluating passively transferred broadly
neutralizing antibodies (bnAbs) suggest that a vaccine capable of eliciting bnAbs would provide
effective protection from HIV infection. However, the difficulty of inducing bnAbs through
vaccination has led to a focus in the field on vaccine strategies based on sequential immunizations
meant to guide the developing B cell response. These sequential immunization strategies range
from germline targeting to lineage-guided design to immunofocusing, and combinations thereof.
While logical from a structural biology perspective, important immunological questions remain
unanswered for such vaccines: In such a strategy, at what interval should sequential immunogens
be administered? How does competition from antigen-specific but non-neutralizing B cell
precursors impact vaccine “shepherding”? Is this sequential immunization process hindered by
limited T cell help? In addition, vaccines comprised of 4 or more injections will be a challenge to
implement globally. How do we make such a vaccine practical? In this phase R61/R33
application, we propose systematic studies in small animal models to evaluate fundamental
vaccine immunology issues facing such strategies. We proposed several novel approaches to
examine, and potentially solve, these issues: In aim 1 we will characterize the immunology of
staggered sequential immunizations, in aim 2 we develop an approach to delete competitor B
cells during vaccination, in aim 3 we develop vaccines employing augmented T cell help, and in
aim 4, we propose technologies to enable sequential immunogen exposure following a single
injection. We will test these concepts in the context of vaccines aiming to elicit bnAbs against the
CD4 binding site (VRC01-class responses) and the Env fusion peptide, using physiologically
relevant conditions. The most impactful of these immunization strategies will be downselected for
testing in non-human primates (NHP) during the R33 phase, the animal model for HIV
immunization closest to humans. Our work is guided by recent advances by the Irvine, Crotty,
and Silvestri labs in understand GC kinetics, bnAb B cell competition,vaccine delivery systems,
novel adjuvants, and roles of T cell help in rare B cell recruitment.

Public health relevance
Project Narrative: Development of a successful HIV vaccine is a grand challenge of modern vaccine science. Recently, the concept of shepherding the immune response toward protective B cell responses through a series of repeated immunizations has shown promise, but many fundamental questions about how such sequential immunization vaccines should be designed and optimized remain unanswered. In this proposal, we aim to develop several parallel practical approaches to enhance the ability of sequential immunizations to drive the development of broadly neutralizing antibodies that have the potential to be protective against HIV infection.